"R-loop formation protects CpG islands against epigenetic silencing".

DESCRIPTION (provided by applicant): Project Summary: CpG islands (CGIs) function as promoters for greater than 60% of human genes. Importantly, these elements remain mostly free of CpG methylation - an epigenetic mark associated with stable transcriptional silencing - despite the fact that the vast majority of CpG sites in the genome are methylated. While the relative immunity of CGIs against epigenetic silencing has been noted for years and is critical to their function, its underlying mechanism has remained elusive. Here, we report three novel and key observations relevant to this process: (i) a large fraction of CGI promoters, while GC-rich overall, display marked strand asymmetry, or skew, in the distribution of G and C residues; (ii) transcription through such regions of high GC-skew leads to the formation of long R-loop structures in which the newly transcribed G-rich RNA remains hybridized to the template C-rich DNA strand, forcing the non-template DNA strand into a largely single-stranded conformation; and (iii) R-loop formation protects the underlying DNA sequence from the action of DNA methyltransferases (DNMTs). Based on this knowledge, we hypothesize that R-loop formation at mammalian CGI promoters serves to protect these regions against epigenetic silencing. We propose to further test this hypothesis through three Specific Aims combining computational, genomics, biochemical, and molecular genetics approaches in human and mouse cells. Specific Aim 1: To test the hypothesis that R-loop formation is a widespread and conserved property of mammalian CGI promoters. Specific Aim 2: To test the hypothesis that R-loop formation protects against DNA methylation. Specific Aim 3: To test the hypothesis that altered R-loop formation leads to aberrant DNA methylation patterns.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project Narrative: This proposal provides a novel framework for understanding CGI promoter function and for addressing how deregulated protection of CGIs often leads to human diseases, including cancer, imprinting, and most importantly, auto-immune disorders such as Aicardi-Goutieres Syndrome. Project Narrative: This proposal provides a novel framework for understanding CGI promoter function and for addressing how deregulated protection of CGIs often leads to human diseases, including cancer, imprinting, and most importantly, auto-immune disorders such as Aicardi-Goutieres Syndrome. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS CpG islands (CGIs) function as promoters for greater than 60% of human genes. Importantly, these elements remain mostly free of CpG methylation - an epigenetic mark associated with stable transcriptional silencing - despite the fact that the vast majority of CpG sites in the genome are methylated. While the relative immunity of CGIs against epigenetic silencing has been noted for years and is critical to their function, its underlying mechanism has remained elusive. Here, we report three novel and key observations relevant to this process: (i) a large fraction of CGI promoters, while GC-rich overall, display marked strand asymmetry, or skew, in the distribution of G and C residues (Fig. 1A); (ii) transcription through such regions of high GC-skew leads to the formation of long R-loop structures in which the newly transcribed G-rich RNA remains hybridized to the template C-rich DNA strand, forcing the non-template DNA strand into a largely single- stranded conformation (Fig. 1B); and (iii) R-loop formation protects the underlying DNA sequence from the action of DNA methyltransferases (DNMTs) (Fig. 1C). Based on this knowledge, we hypothesize that R-loop formation at mammalian CGI promoters serves to protect these regions against epigenetic silencing. This hypothesis provides a novel framework for understanding CGI promoter function and for addressing how deregulated protection of CGIs often leads to human diseases, including cancer, imprinting, and auto- immune disorders. We propose to further test this hypothesis through three Specific Aims combining computational, genomics, biochemical, and molecular genetics approaches in human and mouse cells. Specific Aim 1: To test the hypothesis that R-loop formation is a widespread and conserved property of mammalian CGI promoters. A. Computational approach. "SkewR", an algorithm that detects R-loop forming regions by their GC skew signatures will be optimized and used to generate comprehensive R-loop maps in the human genome and three other vertebrate genomes. This will serve to highlight the function(s) and evolution of this novel class of structural elements. B. Genomics approach. The presence of extensive single-strandedness on the non-template strand of an R-loop provides a means to detect such structures at endogenous loci. Here, we propose to scale up this R-loop footprinting method 1 for high- throughput sequencing and investigate R-loop formation specifically at human CGI promoters. We expect to demonstrate that R-loop formation is a novel and widespread characteristic of these loci. Specific Aim 2: To test the hypothesis that R-loop formation protects against DNA methylation. In a first step, we will test the notion that R-loops are inadequate substrates for de novo DNMTs. For this, the activity of purified human enzymes on R-loop and control substrates will be measured using quantitative methylation assays. In addition, we will determine whether R-loops can recruit H3K4 histone methyltransferases (HMTs), as expected from the recent demonstration that SET1 family H3K4 HMTs avidly bind single-stranded DNA 2. This will be performed both in vitro using purified proteins in quantitative binding assays, as well as in a cell culture system using episomal constructs that carry inducible R-loop forming regions. We expect that R-loops will shield DNA from DNA methylation both directly and indirectly by mediating the recruitment of the protective H3K4me3 histone mark. Specific Aim 3: To test the hypothesis that altered R-loop formation leads to aberrant DNA methylation patterns. A. Reduction in R-loop formation leads to gain of DNA methylation. Ribonuclease HI (RNase HI), which selectively degrades RNA when base-paired to DNA, will be expressed from a Tet- inducible system in murine embryonic stem cells (ESCs) in order to prevent R-loop formation. The resulting effect on the methylation of CGI promoters will be tested by recovering methylated DNA and interrogating CGI microarrays. Chromatin immunoprecipitation will be used to assess how H3K4me3 patterns are affected. We expect that RNase HI expression will lead to depletion of H3K4me3 peaks accompanied by aberrant gains of DNA methylation. B. Enhanced R-loop formation leads to reduced DNA methylation. Short hairpin RNA constructs targeting endogenous RNase HI and II complexes will be stably integrated in murine ESCs in order to favor R-loop formation. The resulting effects on DNA methylation and H3K4me3 patterns will be assessed as mentioned. We expect that enhancing R-loop formation will lead to increased recruitment of H3K4me3 and loss of DNA methylation. In addition, we will examine the distribution of DNA methylation and H3K4me3 in the genome of Aicardi-Goutières Syndrome (AGS) patients who suffer from mutations in the RNase HII complex. We expect that cells from AGS patients will show extensive R-loop formation accompanied by increased H3K4me3 and reduced CpG methylation levels.